Functional analysis of SIRPG, a T cell-specific autoimmune gene

Project Summary
Recent genetic studies have identified numerous genetic variations that are associated with higher risk of
autoimmune diseases. For example, several genetic variations at the SIRPG gene are associated with higher
risk of type 1 diabetes. SIRPG is expressed almost exclusively in T lymphocytes. However, its physiological
function is still unknown due to the lack of a mouse homologue. Nor do we understand how its genetic
variations contribute to the pathogenesis of type 1 diabetes. These important questions will be addressed in
this project with cutting edge genetic engineering technology to ablate SIRPG or reproduce its genetic
variations in human T cells. Data generated from this project will advance our understanding of not only the
function of SIRPG but also the pathogenesis of type 1 diabetes, and eventually lead to novel therapeutic
approaches of autoimmune diseases.

Public health relevance
Project Narrative Recent studies have identified many genetic variations that are associated with higher risk of autoimmune diseases; however, the impacts of the genetic variations on the function of immune cells are often unknown. Better understanding of how the variations influence the function of immune cells may lead to novel treatments of autoimmune disease and improve human health.